Biology of Lymphangiogenesis in the Adult Lung

PROJECT SUMMARY/ABSTRACT
The lung’s lymphatic system plays a critical role in lung health by maintaining fluid homeostasis and by serving
as a conduit for immune cell trafficking. Despite the importance of this network however, there are significant
knowledge gaps in the basic biology of this system and its key cellular constituent, the lymphatic endothelial cell
(LEC). For one, very little is known regarding the origin and replacement of lung LECs in adult life and how
different origins and micro-anatomical locations of LECs might be associated with different roles, specifically in
immune responses. Indeed, whether lung LECs comprise a heterogeneously and functionally distinct set of cell
subtypes or a largely homogenous population is unknown. After instillation of flu into the mouse left lung lobe,
we observed a local and vigorous lymphangiogenic reaction manifested by early vessel dilation followed by
expansion of the lymphatic network itself. This is associated with a significant 1.5-2-fold increase of LECs at 7
days post-infection (dpi) and a significant 2-3-fold increase at 21 dpi, a time when the virus is cleared. Edu
labeling demonstrated that 20% of LECs are proliferating at 7 dpi vs. <1% in control mice. These data along
with observations suggesting 2 distinct sources of adult LECS, one fetal and from a venous origin, and one post-
natal and from a myeloid origin, underscore the potential for LEC heterogeneity both functionally and micro-
anatomically. This will be addressed in Aim 1 by evaluating the role and localization of these 2 sources of LECs
during adult lung homeostasis and viral-induced lymphangiogenesis by lineage tracing. These studies will be
supplemented by single nuclear RNA sequencing in Aim 2 to generate LEC specific genetic information that will
be key to understanding LEC heterogeneity and immune response to infection, along with derivation of LEC
subset tissue localization markers. We also found that the flu-infected lung is characterized by decreased LEC
nuclear localization of YAP and TAZ, which are the primary transcriptional effectors in the Hippo signaling
pathway. This highly conserved pathway is a central regulator of cell phenotype in many biological systems with
decreased nuclear YAP/TAZ signifying signal inhibition. Taken together, these findings suggest that the status
of Hippo signaling may be a key factor regulating LEC proliferation and phenotype. Lastly, we observed vigorous
LEC proliferation in the contralateral uninfected lung, suggesting the interesting possibility that LEC proliferation
is a systemic response to flu. These issues will be further studied in Aim 3 by the selective deletion of hippo
signaling in LECs and by examining lymphangiogenesis in liver and heart in our flu model. In sum, we posit that
the state-of-the art shows a pronounced need for basic information that can resolve fundamental questions in
the field of lung lymphatic biology. With strong background data and robust models, we believe that the studies
in this grant will help to resolve these basic questions, and as result will expand and deepen our understanding
of LEC origin, mechanism of expansion, heterogeneity, function, and phenotype regulation.

Public health relevance
PROJECT NARRATIVE The overall goal of our grant is to understand the basic biology of cells that line the lung’s lymphatic system. These cells are termed lymphatic endothelial cells and to date, very little is known regarding the origin of these as new lymphatics arise in adult life and whether these cells represent a homogeneous population or a set of cell subtypes each with distinct functions in health and diseases, in particular infections. Our hope is that these studies will provide important information that can be used to develop new and effective treatment strategies for respiratory viral infections.